Clinical and Translational Core

ABSTRACT
The overall objective of the Clinical and Translational Core is to provide an easily accessible, modern, and
local resource for translational studies of aging. Ultimately, this will result in a valuable and sustainable
resource for the biomedical research community. Project leaders will be able to assess age-related biological
and clinical phenotypic changes over the adult lifespan, utilizing a prospectively collected dataset, from a
genetically homogeneous population. Thus, it will be possible to study the aging process in humans over
decades – from middle age to extreme old age – by accessing archived biological specimens and clinical data.
This approach provides major advantages over commonplace short-term studies of intermediate phenotypes of
aging. It also eliminates recall bias and other bias seen in studies which use cross-sectional or retrospectively
collected data.
The central hypothesis for this Clinical and Translational Core is that by providing a unique biorepository
and clinical dataset for aging studies, the expertise to manage and share such data, and opportunities for
education and training in translational aging research, we can optimize opportunities for novel discoveries for
healthier aging by a new generation of interdisciplinary investigators. The Kuakini Medical Center Honolulu
Heart Program (Kuakini HHP) studies provide a unique opportunity for ongoing research on healthy aging due
to the large homogeneous study population, high quality clinical data, long, follow-up (fifty-two (52) years and
ongoing), large number of very old, healthy persons, and large collection of biospecimens. Also, Kuakini
Medical Center has sponsored and funded an ongoing study of the sons and daughters of the Kuakini HHP
cohort in the recent Kuakini HHP Offspring Study.
The Clinical and Translational Core is crucial for collecting, archiving, managing, and providing
biospecimens and clinical data for collaborative studies on aging. This Core is designed to: (i) Identify and
recruit 800 participants through the Kuakini HHP Offspring Study; (ii) Collect clinical phenotypic
information on health and physical/cognitive function, as well as blood, DNA, RNA, and establish cell lines;
(iii) Test for specific genotypes and assess phenotypes of aging in both Kuakini HHP men (original cohort)
and Kuakini HHP Offspring Study (new offspring cohort of men and women); and (iv) Provide the Projects
with biological, demographic and clinical phenotypic information on the Kuakini HHP cohort and Kuakini HHP
Offspring Study.
The following aims support the goals of the Clinical and Translational Core:
AIM 1: (a) Collect biological and clinical phenotypic information on health and physical functions from
offspring of Kuakini HHP participants; and (b) Provide this information to the Projects and archive
biospecimens and clinical data for future projects. We propose to recruit a stratified random sample of 800
Japanese-American Kuakini HHP Offspring Study participants (ages 40 to 90+ years). We will oversample
families with longevity and obtain a random sample of offspring of average-lived parents to optimize aging-
related outcomes. We will collect demographic, clinical and cognitive information, and biospecimens for
current and future projects.
AIM 2: Conduct follow-up for clinical outcomes. The clinical outcomes include onset of diseases, disability,
tracking of mortality, and ascertainment of cause of death.
AIM 3: Optimize biospecimen and clinical data for aging research and coordinate data management.
We propose to: (i) Regenerate the genome of decedent Kuakini HHP men, utilizing DNA amplification
technology, and stored serum from the early 1970s. This will provide: (a) The largest (n= ~7,000) and longest
(almost five decades) follow-up of a cohort for aging outcomes; (b) The ability to assess the influence of
genetics on aging-related phenotypes from middle age to death; and (c) Markedly increase statistical power;
(ii) Genotype Kuakini HHP men and Kuakini HHP Offspring Study participants (sons and daughters) for
longevity-related genes including FOXO3; (iii) Establish additional lymphoblastoid cell lines; (iv) Perform RNA
Sequencing on Kuakini HHP Offspring Study participants; (v) Create novel aging phenotypes from stored
blood and tissue for serial measurement of aging-related phenotypic change over most of the adult lifespan
(ages 40s to 100s) for future projects; (vi) Update, merge and integrate the Kuakini HHP and other Kuakini
aging-related studies into a common dataset; (vii) Manage access to data for all current and future projects,
program datasets for statistical analyses, conduct data analysis; and (viii) Assist investigators with Clinical and
Translational data interpretation.